Neural basis of collective behavior during environmental stress

Project Summary
Social interactions are critical to the physical and emotional health of a wide variety of species.
Perturbations in social functioning, a hallmark symptom of many psychiatric and neurodevelopmental disorders
such as autism and schizophrenia, can profoundly impair an individual’s ability to sustain healthy social relations.
While a growing body of literature has elucidated neural circuits for dyadic social interactions (interactions
between two individuals), our understanding of higher order interactions at the level of larger groups is
remarkably weak. Humans and other species organize themselves into social groups, in which the behavior of
each individual both contributes to and benefits from the cohesiveness and well-being of the collective. Social
groups serve as a context for sharing of resources, buffering of stress, regulation of homeostatic needs, and a
reservoir of cognitive capacity to solve problems and respond to environmental challenges. In order to address
this gap in the literature, I am using a novel behavioral approach to study how groups of mice self-organize into
huddles in response to a cold temperature thermal challenge. Prior studies examining social groups have been
limited by lack of technology to track the pose and identity of each mouse over the duration of a session. To
address these challenges, I am using novel multi-animal pose estimation tools developed through computer
vision to quantitatively identify huddling configurations in groups of four mice. Furthermore, I am combining this
automated behavioral tracking with circuit dissection tools to understand which circuits in the brain coordinate
huddling in response to thermal challenge. Published work from our lab and others suggests that medial
prefrontal cortex (mPFC) is a critical node involved in regulating group level behaviors and inter-brain dynamics
across species. However, the contribution of mPFC and its descending projections to group huddling has never
been explored. Furthermore, although whole-brain knockout studies have found that the social hormone oxytocin
is necessary for huddling in mice, the precise neural circuits that are engaged by oxytocin to promote huddling
never been examined. The experiments described in this proposal will fill a critical gap in our understanding of
neural mechanisms for collective behavior by performing detailed quantitative behavioral analysis and neural
circuit dissection to physiologically observe, computationally model, and functionally manipulate individual
descending projections of the dmPFC during huddling. Using an ethologically relevant group behavior, in vivo
freely moving calcium imaging, chemogenetic manipulations, and anatomical mapping, the proposed study will
test the hypothesis that oxytocin engages discrete, anatomically-defined pathways descending from the dmPFC
to promote group huddling. These results will set the foundation for a more incisive analysis of how dmPFC
circuits shape social function in both health and disease. In addition, completion of this work will provide critical
training in statistical and machine learning approaches to study the behavior and neural dynamics of social
groups, which are essential for the candidate to become a successful independent investigator.

Public health relevance
Project Narrative Humans and other animals organize themselves into social groups in which each member both contributes to and benefits from the well-being of the whole, especially in the presence of environmental challenges—however little is known about how group level interactions are coordinated by neural circuits. Using cutting-edge tools for automated behavior tracking and neural circuit dissection, this proposal will examine how medial prefrontal cortex projections regulate group behaviors during environmental stress. This research will enhance our understanding of how social behaviors at the level of the group are coordinated by the brain, and will pave the way for more effective therapeutic strategies to combat social response to challenge and stress in humans.